3D bioprinting of a bilayered, tissue engineered cornea

Corneal blindness is a leading cause of visual impairment, affecting an estimated 12.5 million people worldwide.
Corneal transplantation, or keratoplasty, is the only curative treatment for corneal blindness, yet the cadaveric
donor tissue required for this sight-restoring procedure is available to less than 2% of patients worldwide. While
several different tissue-engineered corneal transplants have been proposed, designing therapies with the long-
term transparency and regenerative capacity of a human donor cornea remains a formidable challenge. The
native cornea is a multi-layered tissue, with each layer playing a distinct role in the overall corneal function;
however, most tissue-engineered corneas to date have been monolithic structures. Here we propose leveraging
recent advances in 3D bioprinting to fabricate a bilayered, tissue-engineered cornea, with each layer fabricated
from a customized biomaterial formulation with optimized print parameters to achieve the desired biofunctionality.
This technology builds on our recently reported family of UNION bioinks that form cohesive, strong interfaces
between distinct biomaterials when 3D-printed into a tissue-engineered construct.
In Aim 1, we design a 3D-printed stromal layer with encapsulated corneal stromal stem cells (CSSCs) that resists
contraction, remains transparent, and secretes pro-regenerative paracrine signals. While CSSCs have the
potential to reduce scarring, their contractile phenotype leads to deformation of engineered tissue, altering the
shape, size, and transparency over time. We hypothesize that covalent crosslinking of a chemically modified
collagen type I bioink will enable printing of a mechanically robust hydrogel with ordered fibrils that guide cell
alignment and phenotype. Our preliminary data demonstrate that bio-orthogonal azide-alkyne click chemistry
crosslinking resists cell-induced deformation and promotes cell alignment. In parallel, in Aim 2, we design an
acellular 3D-printed basement membrane layer that promotes corneal epithelial cell (CEC) migration and forms
a cohesive interface with the 3D-printed stromal layer. CECs are known to alter their migration in response to
properties of their underlying basement membrane, which is distinct from the stromal layer. Clinical translation
requires a cohesive interface between these two layers to maintain a stable graft. We hypothesize that a thin
layer of printed protein can be formulated to promote migration of endogenous CECs while maintaining a
cohesive interface with the underlying stromal layer through bio-orthogonal covalent crosslinks. The bilayer
construct will be evaluated in an ex vivo rabbit eye model to quantify the migration of endogenous CECs in
response to secreted signals from the encapsulated CSSCs. In Aim 3, we evaluate the translational potential of
the 3D-printed, bilayered corneal tissue in a preclinical rabbit model of keratoplasty. The rabbits undergo a 5.0-
mm keratectomy to excise a central corneal stromal scar and will be treated with the full bilayer construct, the
bilayer construct without CSSCs, and a monolayer construct without the engineered basement membrane.
Injured, untreated animals are negative controls, and the uninjured eye in each animal are positive controls.

Public health relevance
PROJECT NARRATIVE Corneal transplantation, or keratoplasty, is the only known curative treatment for corneal blindness, yet the cadaveric donor tissue required for this sight-restoring procedure is available to less than 2% of patients worldwide. While several different tissue-engineered corneal transplants have been proposed, designing multi- layered constructs with the long-term transparency and regenerative capacity of a human donor cornea remains a formidable challenge. Here we propose leveraging recent advances in 3D bioprinting to fabricate a bilayered, tissue-engineered cornea, with each layer fabricated from a customized biomaterial formulation with optimized print parameters to achieve the desired biofunctionality.